Investigating Neisseria gonorrhoeae chromosomal replication dynamics

PROJECT SUMMARY
Neisseria gonorrhoeae (Gc) causes one of the most common sexually transmitted infections.
Increasing antimicrobial resistance is a major public health issue. Gc has more than one copy of
its chromosome per cell, while a closely related commensal Neisseria has a single chromosomal
copy. I have identified the putative origin or replication (oriC) and will determine the minimal oriC
sequence and which conserved sequences are required for replication and growth. I will also
determine whether oriC can drive the replication of an extrachromosomal episome. Additionally,
I will determine whether DnaA protein levels are responsible for regulating chromosomal copy
number. Finally, I will determine whether the oriC controls chromosomal copy number by
swapping the oriC sequences between polyploid Gc and the commensal monoploid N. lactamica,
and if they can, whether this alters ploidy status and other aspects of Gc physiology and genetics.
This study will provide the first molecular characterization of the Gc oriC and the role of polyploidy
in Gc genetics and physiology. Understanding the fundamental mechanisms of chromosome
replication initiation and the maintenance of polyploidy status may reveal insights into mutation,
antibiotic resistance generation, and diversification processes.

Public health relevance
PROJECT NARRATIVE We will define the minimal sequences required for Neisseria gonorrhoeae chromosomal replication and determine how multiple chromosomal copies are maintained. Through genetic approaches and mutagenesis experiments, I will define the origin of replication (oriC) and the role of the replication initiator protein DnaA on chromosomal copy number. This study will advance our understanding of gonococcal genome organization and replication control, potentially revealing new targets for treating gonorrhea.